Sex and stress hormones control adrenal gland macrophage development and function"

Abstract:
Chronic stress promotes a systemic inflammatory response that contributes to cardiovascular and
metabolic disease (CVD), and even acutely augmented stress can exacerbate disease severity. In humans,
consumption of high fat/high cholesterol diet (HFD) is a common co-factor driving chronic stress responses.
Understanding mechanisms controlling the stress-response and its association with CVD diseases, which are
nearly ubiquitous and a leading cause of mortality, will allow for development of impactful translational
approaches to fight against this understudied disease. The AG is the primary source for steroid hormones,
corticosterone and aldosterone that are produced in the cortex. Elevated corticosterone modifies glucose
homeostasis, immunity, and tissue remodeling. Our prior work using a cold-temperature stress model showed
that cold-stress drives the promotion of monocyte egress from bone marrow and exacerbated atherosclerosis.
Therefore, we sought to determine whether the local immune cells in the AG were also responding to stress
responses, either through cold-exposure or HFD feeding. Interestingly, we observed accumulation of lipid
within AG resident macrophages sitting adjacent to hormone-producing endocrine cells in models of
atherosclerosis, hypertension, or acute cold challenge. Tissue resident macrophages are typically tissue repair
cells and lipid accumulation is associated with anti-inflammatory phenotypes in macrophages. AG
macrophages have not been thoroughly described in literature, and their function in response to hormone
signals is unknown. Through our preliminary studies of WT mice (chow-diet fed with no overt stressors), we
identified two primary populations of macrophages present in the AG. These populations showed a sexual
dimorphism in the representation of macrophage subsets when comparing adult male versus female mice.
Furthermore, through single cell RNAseq profiling between male and female AG immune populations, we
identified gene programs associated with AG resident macrophages and found constitutive expression of the
lipid-sensor Trem2, which was found to increased on AG macrophages following chronic challenge, supporting
a role in responding to lipid-hormones. Loss of Trem2 was associated with lipid accumulation in the AG and
elevated circulating corticosterone levels in the absence of challenge. Together, these observations led to the
overarching hypothesis AG resident macrophage maintenance is controlled by sex hormone production,
and that AG macrophages sense steroid hormones during stress responses to dampen inflammation
and promote tissue health. Our extensive experience in studying tissue macrophage development and
function, along with the utilization of new animal models make our group ideal to test these novel concepts. If
true, the implications of this study will identify new approaches to regulate systemic inflammation responses
through the modulation of AG associated macrophages, which might complement current lipid-control
approaches used for high-risk CVD patients.

Public health relevance
Project Narrative: Stress hormones are produced by the adrenal gland and promote systemic inflammation that contributes to cardiovascular and metabolic disease, which are two of the leading causes of morbidity and mortality worldwide. We will address sexual dimorphisms associated with adrenal macrophage development and their contribution to regulating the stress response following acute and chronic challenge models, and predict resident macrophages play a direct role in regulating this response. This study will provide definitive answers to adrenal macrophage ontogeny, onset of sexual dimorphism, heterogeneity, and responses to both acute and chronic stressors, knowledge that is essential for the development of therapeutic approaches to combat features of chronic stress that underlie high risk cardiovascular disease patients.